Olympus FV3000 Confocal Microscope

3302116123652526732896623961921366525591896222339.991566961866595213611236"(2#56)6$366%19351586123261*!2532+3569595969325$529$&',3256839285659535323511632366291-52&'/19186663321936132131129237863512921
3022399666833931652$5959323696589931166389552699122636163633$6633926952953889568565353662329651212581938595959139 5$59311/56666573802166619239522593303196633339966
29"2)9131166"63646998655683886966991361566,36666963966325665996$1269636555526236259869995321566691926322959225269,6122833236339691966923332616626.9,32353669952556938231966686666595668166795276526681366233995116222662336292821339262356998606(9912239262139362256632619291659633259226953825696862390686881555353962926263961536396925619632662699326338293386695586559953661668332692613929(162935266923733829698256965524363,96326)92032659/3316666903)966981163"4668939633931518965981169656669!51325528632363"652396636256265,25596331962959
53"92695835,6283625(66636365026653!259;6"36769520(!666"53256695861392621916262966191092283!5"22319293889252959621226366893395689599363631925169825921126639936936193156685758925266526662996259636638605651235636316652:2398*0921681665269633285535696362636365632/29300!!""
/782322923956 9911665678856396329223958369922366633655295638365519916)"4 865636512912916 1

Public health relevance
The ability to image cellular events and physiological processes is essential to the development of new pharmacological therapies and drug delivery strategies. The School's existing confocal microscopy is at the end of its operational life span and needs to be replaced. The instrument requested will support a large number of NIH-funded projects, enabling investigators to perform real-time detailed analyses of living cells and organoids. These studies will result in the development of new and effective treatments for a wide variety of disorders including cancers, liver disease, viral infections, hemorrhagic shock, and others.